The Role of NFkB in Chronic Inflammation, Microglia Priming, and Neuropsychiatric Complications Following Diffuse Traumatic Brain Injury

Project Summary/Abstract
Traumatic brain injury (TBI) is one of the foremost causes of death and disability in the United States. Most brain-
injured individuals (~70%) develop neuropsychiatric or neuropathological complications, including depression,
cognitive decline, epilepsy, or neurodegenerative disease, that negatively affect health and lifespan. Microglia
are the resident innate immune cells of the brain and respond to insults, like TBI, that cause cell damage. While
an early inflammatory response is often beneficial, chronic inflammation is detrimental and prevents return to
brain homeostasis. Microglia reactivity is evident long after injury, and microglia are chronically hyper-reactive,
or “primed,” to respond to secondary challenges. Secondary challenges include infections, which are common
in the general population. In experimental studies, hyper-reactivity of microglia after TBI is associated with
exacerbation of depressive-like behaviors, cognitive decline, and development of epilepsy. Though TBI is highly
prevalent and associated with chronic disability, there are no current FDA-approved treatments for improving
long-term outcomes. Furthermore, the link between inflammation after TBI, microglia priming, and poor long-
term recovery is not understood. In this proposal, I will explore the role of NFkB, a prominent mediator of
inflammatory gene expression, in propagating chronic microglia primed profiles and hyper-reactivity to secondary
challenges. In Aim1, I will determine the therapeutic potential of an NFkB inhibitor to prevent chronic microglia
activation and neuropathology (Aim1a), as well as microglia hyper-reactivity to secondary immune challenge
associated with exacerbated sickness and depressive-like behaviors (Aim1b). In Aim2, I will focus on
mechanism by using transgenic mice to determine if microglia-specific NFkB activation drives inflammation after
TBI (Aim2a) and if microglia-NFkB activation contributes to epigenetic modifications in microglia that underlie
enhanced reactivity (Aim2b). To complete these aims, I will have the support of 2 sponsors, as well as
consultation with my other 3 committee members and bioinformatics experts at OSU. I am accomplished in
several techniques that will be used throughout this proposal (midline fluid percussion injury, nCounter
NanoString for gene expression analyses, immunofluorescent labeling, imaging, and quantification of gliosis) but
will additionally add techniques to my skillset, including bulk RNA-sequencing, multi-ome single-nuclei RNA- and
ATAC-sequencing, depressive behavioral assays, and neuropathology assessments. With the support of
multiple OSU Core Facilities and Shared Resources (10X Genomics Platform, Flow Cytometry Core, and the
OSU Comprehensive Cancer Center Genomics Shared Resources) and experts in these areas, I anticipate full
completion of these aims, which will support at least one first-author publication. Attaining an F31 NRSA
fellowship and completing these aims will make me a competitive postdoc applicant and position me to obtain
future funding as I continue my career development into an independent academic researcher.

Public health relevance
Project Narrative Traumatic brain injury is one of the leading causes of death and disability, and even mild to moderate injury is associated with long-term neuroinflammation and neuropathological complications, including depression, cognitive decline, epilepsy, and neurodegenerative diseases. Though TBI is prevalent and associated with high vulnerability to poor outcomes in the majority of survivors, there are currently no FDA-approved treatments to improve long-term outcomes after TBI. In these studies, I will investigate the mechanisms of chronic microglia priming and hyper-reactivity in the hopes of revealing potential therapeutic targets to mitigate negative long-term outcomes.